UC San Diego Clinical and Translational Research Institute

Project Abstract We have established the UCSD Clinical and Translational Research Institute (CTRI), with its hub located at the University of California, San Diego (UCSD). This regional center includes three universities (UCSD, San Diego State University and UC Riverside), 4 biomedical research institutes (Salk Institute, Sanford-Burnham Institute, J. Craig Venter Institute, and La Jolla Institute for Allergy and Immunology), and 3 academic hospitals (UCSD Medical Center, VA San Diego Medical Center and Rady Children's Hospital), one community health center (Palomar Health). The CTSA program encompasses 3 health sciences professional schools (Medicine, Pharmacy, and Nursing) and 2 Master's programs in Clinical Research and Drug Discovery Sciences. The overall program goals are to: 1) Develop an integrated education and training program across the translational science spectrum; 2) Empower community-based partnerships and integrate the stakeholders into translational research governance; 3) Diversify and enhance biomedical informatics infrastructure to provide a secure, confidential and inter-operative platform; 4) Provide administrative infrastructure to manage and improve clinical and translational research; and 5) Provide resources that enhance collaboration, encourage disruptive innovation and support clinical investigation. The CTRI KL2 program will provide a mentored research experience for junior faculty that ensures a diverse future workforce with the required skills for outstanding multi-disciplinary research in human health. Didactic programs will teach key skills in clinical and translational research, including Master's degrees for individuals seeking additional rigor. Mini-sabbaticals will offer experiential training to enhance the scholars' research programs. A Mentoring Core will train scholars to become mentors for the next generation of researchers. Outcomes and tracking will use new informatics tools to determine the impact of the curriculum on long term research productivity.